Top-down and Bottom-up Control of Visual Attention: Evidence from ERPs and Eye Tracking

? DESCRIPTION (provided by applicant): Visual attention is imperative for day-to-day functioning. However, some basic questions about the nature of visual attention remain unresolved. There is currently a heated debate about how visual attention is involuntarily guided. Stimulus-driven theories propose that salient stimuli can automatically capture visual sTo move forward, some reconciliation between these two opposing accounts is urgently needed. The proposed research will test a new hybrid suppression account of attention capture, which posits that attend-to-me signals produced by salient information are suppressed early in visual processing. This top- down suppression signal can be indexed by the PD ERP component. In the proposed experiments, we test the relationship between the presence of behavioral capture effects and top-down suppression. The key prediction is that even when the behavioral capture effects are absent, we should still find a PD event-related potential (ERP) component to salient item. If successful, this hybrid model could resolve a twenty year debate on the nature of visual distraction. The proposed fellowship has several training goals. As a postdoctoral scholar, the applicant would receive training in advanced ERP and eyetracking techniques. The applicant would also gain the valuable opportunity to become a member of the UC Davis research community, which is internationally-renowned for its groundbreaking collaborative research in cognitive neuroscience. This fellowship is vital for the long-term career development of the applicant, who seeks to develop an independent research program that combines neuroimaging and behavioral techniques to study selective visual attention and high-order visual functioning.

Public health relevance
PUBLIC HEALTH RELEVANCE: The debate in attention capture research is stalling research in several related fields, including basic science research on high-order visual functioning (e.g., visual search), applied human factors research (e.g., designing effective warning displays), and health-related research (e.g., schizophrenia and aging involve failures of visual attention). The current proposal will assess a new hybrid account of attention capture that proposes salient signals are sometimes suppressed by top-down signals, which can be indexed by the PD ERP component. This suppression account of capture makes novel predictions to the two previous theories of attention and if successful, will change the direction of modern attention capture research.